Role of Kir4.1 in regulating NCC and ROMK in DCT

Project Summary/Abstract
Kir4.1/Kir5.1 in distal convoluted tubule (DCT) plays a key role in mediating the effect of low K+ (LK) or high K+
(HK) and low sodium (LS) or high sodium (HS) intake on NCC through Cl--sensitive with-no-lysine kinase
(WNK) which regulates ste20-proline-alanine rich kinase (SPAK), a key kinase for controlling NCC activity.
Although many details of this signaling mechanism explaining the effects of chronic dietary K+ or Na+ intake
have been elucidated, we have demonstrated that chronic perturbations remodel the distal nephron. Thus, the
observed changes may not reflect the initial dynamic response of Kir4.1/Kir5.1 and NCC in the DCT.
Importantly, dietary intake is typically episodic, leading to highly dynamic electrolyte excretory patterns. The
DCT comprises an early part (DCT1) and a late part (DCT2). While basolateral Kir4.1/Kir5.1 and apical NCC
are expressed along both DCT1 and DCT2, the epithelial sodium channel (ENaC) and ROMK are only
detected in the DCT2. This raises the possibility that the response of Kir4.1/Kir5.1 and NCC to short-term
dietary K+ or Na+ may differ between DCT1 and DCT2, contributing to rapid homeostatic effects. We now
hypothesize that dietary K+-intake induced regulation of Kir4.1/Kir5.1, WNK and NCC is initiated
predominantly in the DCT1, whereas dietary Na+-induced or AngII-application-induced regulation of
Kir4.1/Kir5.1, WNK, NCC is started mainly in the DCT2 via type 1a angiotensin II receptor (AT1aR). This
hypothesis is supported by several lines of preliminary data:1) Overnight LK intake stimulates Kir4.1/Kir5
activity in the DCT1 but not in the DCT2; 2) Overnight LS intake increases Kir4.1/Kir5.1 currents predominantly
in the DCT2 but to a lesser degree in the DCT1; 3) Deletion of AT1aR in the kidney abolishes the overnight-
LS-induced stimulation of Kir4.1/Kir5.1 of the DCT and NCC; 4) Acute application of AngII stimulates
Kir4.1/Kir5.1 only in DCT2 and enhances NCC function; 5) Overnight AngII infusion robustly stimulates
Kir4.1/Kir5.1 activity in DCT2 but to a less degree in the DCT1; 6) Overnight AngII infusion stimulates WNK4
and NCC expression/activity in Kcnj10-/- mice but not in Kir4.1 knockout mice. The three specific aims of the
proposal are: 1) Test whether dietary K+ and Na+ induced regulation of Kir4.1/Kir5.1, WNK and NCC is different
between DCT1 and DCT2; 2) Test whether acute or overnight AngII treatment activates Kir4.1/Kir5.1 and NCC
predominately in the DCT2 but not in the DCT1 and that the activation of Kir4.1/Kir5.1 is essential for acute but
not chronic AngII-induced stimulation of WNK4 and NCC 3) Test whether deletion of AT1aR impairs the
stimulatory effect of overnight LS but not overnight LK on Kir4.1/Kir5.1, WNK4 , pNCC and K+ homeostasis.
The physiological significance of the proposal is to elucidate the mechanisms underlying dual regulation of the
DCT, such that DCT1 behaves like a “K+-sensor” and DCT2 behaves like a “Na+-sensor”. This differential
response is essential for normal physiological homeostasis during short-term alterations in K+ or Na+ intake.

Public health relevance
NARRATIVE: Abnormal potassium and sodium transport occur commonly in the setting of chronic kidney disease and heart failure. We have now identified a novel mechanism by which the kidney can sense the change in dietary K+ and Na+ content and regulate K+ and Na+ excretion or absorption. The new concept will expend the current knowledge regarding renal K+ and Na+ transport and may lead to development of new approach for treatment of hypertension and dyskalamia.